Impact of infection complexity on P. falciparum sexual commitment and gametocytemia

PROJECT SUMMARY
Since the 2007 call for malaria eradication, research and programmatic efforts have shifted from controlling
malaria through identification and treatment of clinical disease to elimination of infection and interruption of
malaria transmission. Efforts to reduce malaria transmission include interventions to kill the mosquito vector
and/or reduce vector biting or to reduce human to mosquito transmission of gametocytes, the sexual stage of
the malaria parasite, through treatment or transmission-blocking vaccines. Recent studies have delineated the
molecular mechanisms underlying parasite sexual commitment and gametocyte development. In particular, the
identification of AP2-G as a master regulator of gametocytogenesis has allowed quantification of parasite sexual
commitment based on estimates of ap2-g expression. Approximately, 1 – 30% of parasites in an infection
express ap2-g, suggesting that not all asexual parasites in an infection commit to produce gametocytes.
However, the factors that contribute to parasite investment in sexual reproduction are not fully understood.
Several studies have identified associations between host, parasite, and environmental factors and
gametocytemia. A potentially important factor that requires more in-depth evaluation is the impact of polyclonality
on parasite sexual investment. Evolutionary theory suggests that competition of co-infecting parasite clones in
a polyclonal infection can influence the balance in investment in asexual replication versus sexual differentiation;
however, limited research has been performed to understand how within-host clone interactions impact
gametocyte production in P. falciparum infections. Because a large proportion of infections in high transmission
areas are polyclonal, understanding how infection complexity impacts sexual commitment and gametocytemia
is important for predicting the impact of new interventions on malaria transmission. Likewise, as transmission
(and infection complexity) decrease in response to interventions, understanding the relationship between
infection complexity and transmission may allow identification of transmission reservoirs in the face of changing
malaria epidemiology. In this study, we will examine the impact of host, parasite, and environmental factors on
P. falciparum sexual commitment and gametocytemia in infections occurring in a longitudinal cohort study
conducted in Malawi, based on expression of the ap2-g gene and male and female gametocyte-specific genes.
In addition, we will use a newly developed gametocyte genotyping marker to examine how infection complexity
and clone composition are associated with relative frequency and/or presence of gametocytes of a given clone
within an infection. By investigating these factors in parasites from individuals followed longitudinally, we hope
to gain insights into parasite biology and the impact of infection complexity on parasite sexual investment, and
to discover actionable associations that allow identification of target populations for transmission-reducing
interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE As programmatic and research efforts shift from malaria control to malaria elimination, understanding host, parasite and environmental factors that contribute to parasite investment in sexual reproduction versus asexual replication will be critical for predicting the impact of new interventions on malaria transmission. In this study, we will examine the effect of host, parasite, and environmental factors on P. falciparum sexual commitment and gametocytemia in the context of a longitudinal cohort study, with particular emphasis on the impact of infection complexity and clone composition on gametocyte production by a given clone. In addition to providing important insights into parasite biology, we anticipate that this research will provide actionable associations to predict transmission reservoirs and identify target populations for transmission-reducing interventions.